Rapid Detection of Antibodies to Adenovirus 36

DESCRIPTION (provided by applicant): Adenovirus 36 (AdV36) causes increased adiposity (leading to obesity) and metabolic changes in animals. Causation in humans has not been established, but the infection is associated with the same changes as seen in animals, i.e. increased adiposity, weight gain, and decreases in serum lipid and fasting glucose. Elucidation of AdV36's role in the current obesity epidemic will rely, in large part, on longitudinal studies o large populations. Also, understanding AdV36's effects may have implications for the planning and success of novel intervention strategies for obesity. Given the strong association of AdV36 and subsequent effects in infected humans, failure to understand AdV36's role in obesity would ignore a key risk factor in obesity and continue to follow an obesity paradigm that has largely failed to lead to effective prevention and control strategies. A major methodological barrier exists to studies of large populations needed to move the field forward. That is, the gold standard and currently the only specific method for detecting AdV36 antibodies is the serum neutralization assay (SNA)-a complicated and time-consuming method that has produced inconsistent results among laboratories. In its place, a rapid, high throughput, easy to perform, and objective assay is urgently needed to open the field to new investigators, advance the pace of current studies, and improve consistency of results. This application will develop an improved assay by identifying specific epitopes on the AdV36 hexon protein and using recombinant proteins and/or peptides in a simple ELISA-based system to detect evidence of AdV36 infection, i.e. specific (neutralizing) antibodies. The AdV hexon protein is involved in initial interactions between the virus and host cell and contains specific neutralization epitopes. The AdV36 hexon sequence has been compared to other adenoviruses, revealing nine hypervariable regions (HVRs) likely to contain one or more specific epitopes. We have cloned and expressed four recombinant fusion proteins containing AdV36 HVRs and tested each using SNA-identified positive or negative sera. Two recombinants show promise for development of a sensitive and specific assay but require further characterization and validation. Further, overlapping peptides based on HVR sequences from these recombinants will be synthesized and tested for use in an assay system. Recombinants and/or peptides identified as containing AdV36-specific epitopes will be used in an ELISA to test 300 individual sera with known SNA titers. Comparison of results between the two test systems will demonstrate the sensitivity and specificity of the new assay. In summary, a sensitive, specific, and rapid assay system that no longer depends on cell culture and live virus is essential. Without an improved methodology, studies of AdV36's role in obesity will be slow, carried out by only a few investigators, and fraught with inter-laboratory variability in results.

Public health relevance
PUBLIC HEALTH RELEVANCE: Adenovirus 36 causes obesity in animals and is suspected of having the same effect in humans. However, AdV36 research involving human populations is slow due in large part to the difficult and lengthy serum neutralization assay, which is the curren state of the art method to identify AdV36 antibodies (i.e. evidence of infection). This application describes a two pronged approach to developing a new assay system that will be a rapid, cost-effective method yielding objective results and greater reproducibility between laboratories. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The complexity, time and expense of the current gold standard for Adenovirus 36 (AdV36) antibody detection, the serum neutralization assay (SNA), precludes many laboratories from undertaking AdV36 studies. The SNA is highly specific, but has numerous disadvantages:1) it requires continuous maintenance of cell cultures; 2) active (live) virus must be cultivated and manipulated; 3) it is time intensive to set up and review; 4) review is subjective requiring technical expertise to recognize cytopathic effects of the virus; 5) only 3-4 sera can be tested in each 96-well microtiter plate; and 6) it requires a 13 day incubation time. Further, the inherent difficulties of the assay and subjectivity of the assessment raise concern regarding comparability of results from different laboratories (Atkinson 2011). The proposed project will develop and validate an improved assay for the detection of serum antibodies to AdV36 that overcomes each of the aforementioned disadvantages. The molecular target for the assay is the AdV36 hexon protein, which contains type-specific epitopes and is the most abundant capsid protein. The ease and stability of this improved method will also open doors for longitudinal population studies necessary to elucidate the role of AdV36 in the development of human obesity. Four recombinant proteins spanning one or more hexon hypervariable regions (HVRs) have been cloned as fusion proteins and purified in our laboratory. In preliminary experiments, recombinants, designated HEX 1-4, demonstrate the presence of one or more epitopes on each. However, detection of type-specific epitopes is confounded by the presence of Adenovirus (AdV) type D subgenus epitopes on the recombinants. To avoid this problem, a series of overlapping peptides based on hexon HVRs will be utilized. A growing body of evidence from our work and others indicates a subset of obesity in humans may be caused by AdV36. AdV36 causes obesity in experimentally-infected rodents, chickens, and non-human primates through up-regulation of adipogenesis, enhancement of glucose uptake, and metabolic remodeling of human adipose tissue. Prevalence of AdV36 infection varies among obese adults and children. Obese adults show greater prevalence of AdV36 infection than the non-obese (30% vs 11%), and infected obese adults are heavier than non-infected obese. The only study among US children reports a higher prevalence of AdV36 infection in obese versus non-obese children (22% vs 4%). We are trained to do the SNA assay, have experience with developing peptides as serological reagents, and have sera from epidemiologic studies of AdV36 in children and adults. Specific Aim 1: Screen 28 peptides with four serum pools: 1) AdV36neg/AdVneg, control sera negative for type- specific and subgenus epitopes; 2) AdV-36pos/AdVpos, positive for AdV36 and other type D (subgenus) adenoviruses; 3) AdV-36neg/AdVpos, negative for AdV36 type-specific epitopes but positive for type D subgenus epitopes; 4) commercially-available mouse polyclonal antibody to human adenovirus (type C) hexons with genus reactivity; and 5) 45 individual serum samples. A subset of the 300 individual sera will include 14 SNApos and 31 SNAneg to screen peptides for reactivity to subgenus versus type-specific epitopes. Hypothesis: AdV- 36pos/AdVpos sera versus AdV-36neg/AdVpos or AdV anti-hexon sera will be able to differentiate between Ad-36 type-specific peptide epitopes and genus- or subgenus epitopes. Specific Aim 2: Validate the peptide-based assay by comparing results (serum titers) of 300 sera tested in the serum neutralization assay. Hypothesis: The rapid ELISA-based assay will provide a sensitive and specific assessment of AdV36 antibody status (positive or negative) and serum titer as compared to the SNA results. The proposed study is expected to provide a rapid, sensitive and specific assay for the detection of AdV36 antibodies, an indicator of infection. This assay is novel and addresses a critical need to allow more investigators to engage in this promising new area for obesity research with a valid and consistent assay. The current SNA has many drawbacks, and results can vary among labs. A rapid method will be cost-effective, allow higher throughtput, be easier to perform and reproducible across laboratories, and attract new investigators to this exciting new area for obesity research.